Research Continuity During Parental Leave

No change from Parent Award

Public health relevance
Project Narrative Adolescent girls and young women in Kenya are disproportionately affected by poverty and HIV. Economic empowerment is a promising poverty and HIV risk reduction strategy. The overall project aims to improve how we measure and address economic empowerment in HIV prevention interventions for AGYW. This supplement aims to provide additional support to Dr. Gichane during the critical period of parental leave and return to work. Supplemental funding will be used to hire a part-time research assistant to maintain IRB protocols, sustain data collection and management, and manuscript development ensuring timely continuation on the parent award.